Statistical adjustments of sample representation in community-level estimates of COVID-19 transmission and immunity

Abstract
Throughout the COVID-19 pandemic, government policy and healthcare implementation responses have been
guided by reported positivity rates and vaccination rates in the community. The selection bias of these test
data questions their validity as measures of the actual viral incidence in the community and as predictors of
clinical burden. Publicly available vaccination data are frequently cited as a proxy for population immunity, but this
metric ignores the effects of naturally-acquired immunity. The health disparities concerning asymptomatic and
symptomatic patients are not yet studied. The proposal develops a valid metric to estimate the true viral incidence
and naturally/vaccine-acquired immunity prevalence in the community, examine the health disparities and social
inequality, and monitor the epidemic over time as an operational surveillance system. The approach collects
routine testing data on SARS-CoV-2 exposure and antibody seropositivity among patients in a hospital system
and performs statistical adjustments of sample representation using multilevel regression and poststratiﬁcation
(MRP), which adjusts for measured differences between the sample and population and also yields stable small
area estimates. The data collection and analysis procedure can provide information to entire communities with
generalizability and focus on burdens within speciﬁc demographics, with close attention to vulnerable populations
on disparities across health outcomes, social determinants, and behaviors. In particular, the research will yield
group-speciﬁc estimates of disparities with respect to asymptomatic and symptomatic patients and how these
discrepancies may impact the socio-demographically dependent spread of disease and its subsequent treatment.
The MRP adjustment will be made publicly accessible via a web interface and promote broad investigations with
integrated data sources toward a national study.

Public health relevance
Narrative This project aims to develop an operational surveillance system based on routine hospital testing to track SARS- CoV-2 transmission and immunity seroprevalence in the community and vulnerable groups over time. The pro- posed statistical methods focus on adjusting sample representation, yielding reliable subgroup estimates, and examining disparities across health outcomes, social determinants, and behaviors. The data collection and anal- ysis procedure will be publicly accessible via a web interface and enhance data harmonization.